Progress to achieving conformance with MFPRS standards.

ALABAMA DEPARTMENT OF PUBLIC HEALTH COOPERATIVE AGREEMENT APPLICATION AND JUSTIFICATION SUMMARY DESCRIPTION The Cooperative Agreement is to provide funding for the ADPH state manufactured foods program to achieve, or work toward achieving, compliance with the FDA's MFRPS national standards. This proposal provides: Justification for a request for funding through the Cooperative Agreement for ADPH to hire 2 additional field staff to work in the manufactured foods program. A general description of duties and activities for the new field staff, the Principal Investigator, and the Program Director, under each of the individual standards, and A target date for completion of the individual standards within 5 years. PURPOSE To provide adequate staffing, with funding for travel and other requirements as needed, to review and inspect each food manufacturing firm in Alabama jointly with the county Public Health Environmental staff. By having adequate specialized staff, ADPH will be able to work toward meeting the MFRPS National Standards as part of an integrated food safety system. PROPOSAL IN GENERAL ADPH will use funds provided by FDA through the Cooperative Agreement to work towards completion of the implementation of the MFRPS program. This will be done in the format of working on completion of each Standard, excluding Laboratory, by the target date of September 30, 2017. This proposal delineates each standard and the work to be done throughout the 5- year program to achieve completion.

Public health relevance
PROJECT NARRATIVE The Cooperative Agreement is to provide funding for the ADPH state program to achieve, or work toward achieving, compliance with the FDA's MFRPS national standards. This proposal provides justification for a request for funding through the Cooperative Agreement for ADPH to hire 2 additional field staff to work in the manufactured food program, a general description of duties and activities for the new field staff, the Principal Investigator, and the Program Director, under each of the individual standards, and a target date for completion of the individual standards within 5 years. Page 1 of 1 __SpecificAimsTextDelimiter__ Specific Aims Alabama Department of Public Health (ADPH) Project: Conformance with the Manufactured Foods Regulatory Program Standards (MFRPS) (U18) The specific aims of this application are to (1) employ two Public Health Environmentalists who are already within the ADPH system and will therefore already have basic training in sanitation issues. (2) provide training as needed and required to become technically proficient in conducting inspections of manufactured food facilities. (3) provide any needed materials and supplies for these Public Health Environmentalists to conduct the inspection and to properly document the inspection results, and (4) the pay travel at the standard Alabama state rate for them to visit the manufactured food foods. The outcome of providing properly trained, technically proficient inspection staff will be to have compliance with the requirements of the Code of federal Regulations as those regulations apply to any specific firm. The ultimate impact of this process will result in a safer food product, including proper labeling, being provided to consumers. The objective of this project is to address and solve the problem of some very technically advanced food processes not having a food safety oversight and inspection by specialized staff members. The manufacturing processes are often specific to the food product and the person conducting the food safety inspection needs background and training in those processes, know how to apply sanitation standards to the process, know the critical control points for any food process, know the implications of a breakdown in the critical control point process, and know how to properly document any observations in the event followup regulatory or legal action is needed.